Adapting SAFETY-A to Support Students Returning to School After Mental Health Emergency Department Visits

Abstract
The objective of this K23 proposal is to enhance the supports available to students returning to school after
mental health related Emergency Department (ED) visits. Many youth are referred to the ED because school
personnel feel unprepared to meet their needs, yet ED clinicians deem that the youth do not require
hospitalization thus facilitating their prompt return to school. There is a growing literature base on supports for
students after psychiatric hospitalization, but the number of students returning directly to school after an ED visit
is much higher than the number of students who are actually hospitalized. Therefore, the focus of this proposal
is on adapting Safe Alternatives for Teens and Youths–Acute (SAFETY-A), a cognitive behavioral therapy-
informed intervention that has been delivered in the ED, for students returning to school. Further, completing the
proposed study and meeting the identified career development goals will establish Dr. Lora Henderson Smith as
an implementation scientist and mixed-methodologist with an expertise in ED to school transitions. This project
is unique in that it is the first to propose an intervention to specifically meet the needs of the growing number of
youth with significant mental health concerns who require an ED visit, but do not meet criteria for hospitalization.
Adapting SAFETY-A will provide schools with a tool to better support these youth.
There is often minimal communication between the ED and schools; however, cross-system communication can
facilitate optimal care for youth. As such, Aim 1 includes the examination of discharge summaries to identify what
recommendations ED clinicians are making for schools to support youth. It is hypothesized that there will be few
recommendations made for how schools can best support youth returning directly to school. Improving discharge
summaries can help facilitate care for youth. We will use data from Aim 1 and principles of user-centered design
to adapt SAFETY-A for students returning to school after an ED visit. The adaptation will be informed by
interviews with key informants including families, school leaders, school mental health professionals (SMHPs),
and ED clinicians. In Aim 3, a cluster randomized controlled trial will be conducted. We expect to enroll 4 schools
and randomly assign 2 to the SAFETY-A condition. We will assess SMHP knowledge and skills pre- and post-
training and implementation as well as SMHP adherence to the adapted SAFETY-A protocol. A small number of
SMHPs will be interviewed about their experiences implementing SAFETY-A. We will also test the feasibility of
methods to assess youth clinical outcomes. The proposed study, aligns with Objective 3.2 of strategic plan
NIMH’s strategic plan (i.e., develop strategies for tailoring existing interventions to optimize outcomes)
and other priorities related to youth suicide and school mental health and will significantly improve SMHP
capacity to support students after mental health ED visits.

Public health relevance
Project Narrative This study includes analyzing discharge summaries and employing user-centered design to inform an adaptation of Safe Alternatives For Teens and Youth – Acute (SAFETY-A) for high school students returning to school after a mental health related Emergency Department visit. User-centered design will be used to incorporate the perspectives of caregivers, school staff, and Emergency Department staff into the adaptation. The adapted intervention, which will be evaluated in a cluster-randomized RCT, will have the potential to promote positive mental health outcomes and reduce youth suicide.